Sexual Orientation and Gender Identity Data Collection in Community Oncology Practice

ABSTRACT
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as
NOT-CA-23-032. This supplement’s goal is to characterize organizational and provider-level factors that
differentiate community oncology practices that collect and use sexual orientation and gender identity (SOGI)
data from those that do not. Sexual and gender minority people (SGM; e.g., lesbian, gay, bisexual, transgender,
intersex, etc.) have received limited cancer research attention, in part because large-scale research efforts are
hampered by lack of consistent collection of SOGI data in oncology practices. Oncology practices may not collect
SOGI data due to organizational- and provider-level barriers, even though SGM cancer patients often want to
disclose SOGI, disclosure of SOGI is correlated with better outcomes among SGM patients, and multiple national
organizations recommend that oncology practices collect SOGI data as part of efforts to reduce SGM disparities.
The NCI Community Oncology Research Program (NCORP) is the ideal network to assess factors leading to
SOGI data collection in diverse oncology settings. In a survey of 271 NCORP practices in 2022, we found that
less than half of practices (42%) were consistently collecting SOGI data. In a separate survey of 257 oncology
providers supported by the American Society of Clinical Oncology (ASCO), we found that collection of SOGI
data at an oncology practice was associated with leadership support, resources for data collection, and belief in
the importance of collecting SOGI data. More detailed exploration of barriers and facilitators to SOGI data
collection is needed to inform SOGI implementation interventions across diverse community oncology practices.
In this study, we will use the Consolidated Framework for Implementation Research (CFIR) to assess
implementation factors such as the geopolitical context of laws where NCORP practices are located that
influence SOGI data collection (“Outer Setting”), the characteristics and contexts of the practices and providers
(“Inner Setting” and “Individuals”), and strategies for implementing SOGI data within each practice’s clinical flow
(“Innovation" and “Processes”). Building on strong preliminary data, we will purposively sample 16 NCORP
practices diverse in geography, practice setting, and current SOGI data collection. We will complete 3 in-depth
interviews at each practice, one each with a direct care provider (e.g., oncologist, nurse, advanced practice
provider), an administrator, and a person responsible for intake data (e.g., front desk staff, IT specialist). Our
specific aims are: 1) To assess which implementation factors are difference-makers in the collection and use of
SOGI data in community oncology using qualitative thematic analysis and Boolean-logic-based configurational
analysis, 2) To explore how SOGI data are collected in community oncology practices, with the goal of collating
practice-driven recommendations for data collection, and 3) To explore how SOGI data are used in community
oncology practices, with the goal of informing a future intervention to improve cancer care for SGM patients.

Public health relevance
PROJECT NARRATIVE In response to NOT-CA-23-032, we propose to look at factors that influence sexual orientation and gender identity (SOGI) data collection in 16 community oncology practices in the NCI Community Oncology Research Program (NCORP) network. We will interview 3 people at each practice (one direct care provider, one administrator, one staff member responsible for patient data collection) and analyze interview transcripts using qualitative and configurational analysis approaches. The long-term goal of this project is to create an intervention to improve systematic collection of SOGI data across practices in this large, national cancer research network.